Multiscale genome engineering to map cis-regulatory variants in human and mouse

PROJECT SUMMARY
Genome-wide association studies (GWAS) have linked 1000s of genomic loci with human traits and diseases.
However, the mechanistic inner workings of these loci are largely unknown, leaving the principal goal of GWAS
– illuminating the causal biological etiology of heritable phenotypes – unfulfilled. Most GWAS loci occur within
noncoding regions of the genome whose functional impact on gene regulation is difficult to unravel. Here, we
propose to develop a high-throughput, integrated genome engineering toolbox to build context-specific maps of
enhancers and variants for immune traits and autoimmune disorders. Our multi-PI team consists of experts in
complementary fields: molecular genomics and CRISPR screens, large-scale human genetics and functional
genomics data analysis, immunology, statistical modeling, and single-cell multiomics. Specifically, we propose
to: 1) Identify genes and cis-regulatory elements (CREs) relevant for T cell function. T cells are a central cell
type implicated in multiple autoimmune diseases. We will first perform genome-wide loss- and gain-of-function
screens for 9 phenotypes reflecting T-cell differentiation and activation using primary human T cells. For top-
ranked genes, we will interrogate CREs near each gene and explore their mechanisms via single-cell profiling
and saturation mutagenesis. 2) Build a context-specific enhancer map of GWAS loci in T cells. We will test 1,000
candidate CREs that overlap GWAS loci using CRISPRi/a screens in the same primary T-cell system,
complemented by single-cell ECCITE-seq to measure effects on the transcriptome and surface proteome. This
will produce a comprehensive map of regulatory elements for a large number of loci, and their context-specific
impact on transcriptomic and cellular phenotypes. Then, we will construct a context-specific variant map of
regulatory elements in T cells by inserting specific alleles via base editing at 100 validated CREs. This will
produce a fine-resolution map of regulatory sites within CREs. 3) Test 100 syntenic CREs from in mouse models
of gut homeostasis and inflammation in vivo. We will focus on T-cell tissue accumulation (reflecting activation
and migration) and alterations in transcriptional and cell surface phenotypes of the migrating cells. By doing so,
we will determine if the relevant variants have similar roles in human disease and provide pathways towards
targeting the pathogenic functions of those genes. Through these Aims, we will build a highly-generalizable
toolkit for multi-scale interrogation of noncoding elements and an accessible, open, and reusable resource of
enhancer and variant effects on molecular, cellular, and physiological traits. Altogether, we will analyze the
regulatory architecture of the genome, leveraging our diverse perturbations and phenotypic layers, and
characterize functional mechanisms of loci associated with autoimmune disorders.

Public health relevance
PROJECT NARRATIVE Understanding the effects of genetic variation on gene regulation is a formidable challenge for interpreting genetic associations with complex traits and diseases. Here, we propose to reveal how genomic variation shapes immune cell and autoimmune disease phenotypes, by developing a generalizable toolkit that leverages cutting- edge gene editing and single-cell profiling technologies to produce high-throughput, genome-wide maps of gene regulatory elements and variants. This open and accessible resource of enhancer and variant effects on molecular, cellular, and organismal phenotypes related to immune function will serve as a crucial knowledgebase for understanding the genetics of autoimmune disorders and therapeutic development.